Developing insertable cardiac monitors to assess social and environmental effects on the autonomic stress response in a nonhuman primate model of aging

Project Summary
The long reach of early life remains one of the most enduring puzzles in human health. From famine to
poverty and neglect, adverse early life experiences lead to higher mortality and elevated risk for obesity,
diabetes, and chronic heart disease. These effects are likely mediated, in part, by the stress response, a
cascade of neuroendocrine, metabolic, and cardiac responses to challenge involving the hypothalamic–
pituitary–adrenal (HPA) axis and the autonomic nervous system. In support, several leading hypotheses
propose that repeated social and environmental stressors—both in early life and adulthood—cause over-
activation of the stress response, chronic stress, and accelerated aging. Long-term studies of natural animal
populations offer compelling models for testing these ideas because they often have fine-grained, prospective,
longitudinal data on social and environmental stressors from individuals across the life course. However,
natural animal models also face considerable challenges in measuring multiple facets of the stress response:
most are constrained to measuring glucocorticoids (GCs) as the sole measure of stress responses, reflecting
just one aspect of the HPA axis with no information on autonomic responses. This limitation has led many to
call for expanded tools to measure stress responses in natural animal models of aging.
Our objectives in this proposal are to: (1) expand the tools for measuring the cardiometabolic
consequences of stress in natural animal models by validating insertable cardiac monitors (ICMs) with
accelerometry to measure heart rate, heart rate variability, and physical activity; and (2) test the social and
environmental drivers of the autonomic stress response and its metabolic consequences. We will develop and
validate ICMs using captive baboons at the Institute of Primate Research in Kenya, and a well-studied, natural
population of baboons in Amboseli, also in Kenya. Prior work in Amboseli has already shown that an
accumulation of harsh conditions in early life and social isolation in adulthood exert profound effects on adult
mortality, setting the stage to probe the stress responses underlying these links. While early life adversity and
social isolation lead to elevated GCs in adulthood, and animals with high lifelong GCs have lower survival, GCs
do not mediate the link between early adversity and life span. Gaining a broader perspective on individual
stress responses and their consequences is an essential next step. The results will contribute the first
prospective, longitudinal data in any species to understand how early life adversity and adult social conditions
interact to shape acute autonomic stress responses, chronic stress, and energy expenditure. This study will
provide a direct link between socio-environmental circumstances, stress responses, and adult health, helping
to identify key targets to mitigate the effects of stress over the life course on aging.

Public health relevance
Narrative The proposed research is relevant to public health because it tests how stressors across the life course— including harsh conditions in early life and challenging social circumstances in adulthood—predict autonomic stress responses and cardiometabolic measures of health. The project validates insertable cardiac monitors for measuring autonomic stress responses in captive non-human primates, and then use this validation to measure autonomic activity in a natural population in response to real-time, longitudinal data on adversity in early life and adulthood. This natural population offers fine-grained data and a simplified model, without the complexities of human health risk behaviors. The project is highly relevant to NIA’s mission of understanding aging processes across the life course by testing how repeated social and environmental stressors cause over-activation of the stress response, as a driver of accelerated aging.